Latinas CaPACES: Connecting and Promoting Active Cancer Engagement Successfully using a Culturally-Tailored Digital Tool to Reduce Delays in Breast Cancer Diagnostic Follow-up Testing and Treatment

Project Summary
Evidence reveals racial/ethnic disparities in the quality of patient-provider communication
among breast cancer patients. Health providers are lacking in the ability to communicate in a
clear and culturally competent manner with Latina breast cancer patients. Among low-income
Latinas who delayed follow-up after receiving abnormal cancer screening results, salient
barriers to follow-up included lack of understanding of the information provided to them about
their mammogram findings and/or the recommended diagnostic procedures, and fear about a
possible cancer diagnosis. Delayed treatment has a significant impact on prognosis and survival
of subsequent breast cancer.
We will design a linguistically- and culturally-tailored digital tool that enhances the
discussion between low-income and low-literate Latina patients by breaking down the
information in clear and comprehensible ways to help the patients better understand what is
being discussed and by removing communication barriers around literacy, numeracy, and
education. Patients will also remember what is discussed as all the visual activity that occurs on
the screen can be saved as an animation and shared with family members. The digital tool will
also address the structural barriers encountered by low-income and low-literate Latina
patients by providing an interactive module that connects patients to needed resources.
Culturally- and linguistically-tailored communication between patient navigators and patients has
the potential to have significant positive impact: increased level of breast cancer knowledge, a
greater level of understanding and retention of what was discussed during the encounter, and a
higher level of communication satisfaction with the peer navigator.

Public health relevance
PROJECT NARRATIVE Clear Session, Inc. will develop a culturally- and linguistically-tailored interactive digital tool that visually enhances and documents live conversations to reduce delays in diagnostic follow-up testing and treatment among low-income and low-literate Latinas.